AMP-AD Brain Proteomic Network Enhancement, Validation, and Translation into CSF Biomarkers

Project Summary
The overarching goal of the AMP-AD 2.0 research plan is to generate and analyze RNAseq, whole genome
sequencing (WGS) and proteomic data from the dorsolateral prefrontal cortex (DLPFC) and conduct comparative
studies using the data generated on this project with the AMP-AD RNAseq, WGS and proteomic data generated
on Caucasian cohorts in AMP-AD 1.0. In addition to generating genomic and proteomic data on diverse post-
mortem brain samples, this project will also generate WGS and proteomic data on CSF and matching plasma
samples collected from additional 325 diverse well-phenotyped individuals (Emory Cohorts). The 325
CSF/plasma samples (including ~146 African Americans) are from individuals with cognitive data. This
supplement will support the WGS from these 325 participants that will be integrated with additional
proteomic data (CSF and plasma).

Public health relevance
Project Narrative Multi-omics profiling and analysis of samples from diverse cohorts is essential for the discovery of the full spectrum of therapeutic targets and biomarkers that will be of utility to all populations affected with Alzheimer’s Disease. This supplement will support the whole genome sequencing (WGS) of 325 diverse and well-phenotyped individuals that will have corresponding proteomic data on CSF and matching plasma.